PURIFICATION AND PROTEIN CHARACTERIZATION OF MOUSE BM180

DESCRIPTION Celiac disease (gluten intolerance) and Sjogren's syndrome (ocular component is 'Dry eye') are autoimmune diseases in which patients develop antibodies to the wheat storage protein a-gliadin. Both diseases affect epithelial cells (intestinal epithelial for Celiac disease; lacrimal acinar for the ocular component of Sjogren's syndrome) which have in common an intimate basal association with a thin extracellular matrix known as "basement membrane". In a functional screen for basement membrane component(s) which might be required for normal lacrimal acinar cell secretory function the principal investigator's lab identified a novel 180 kDa cell adhesive protein, BM180, whose N-terminus shared sequence identity with a-gliadin. This unusual observation, made by foreign investigator while a visiting associate in the PIs lab, was reinforced by reactivity of monoclonal anti-a-gliadin antibodies with a 180 kDa protein in basement membrane and by high stringency hybridization of a-gliadin cDNA with genomic human, mouse and rat DNA, and with lacrimal mRNA of 2.3 kb. A logical extension of these data is that BM180 is an autoantigen in these two common diseases - particularly Celiac disease where circulating anti-a-gliadin antibodies have received more attention. Building on past collaborations and the expertise of the foreign collaborator, this project proposes to: (1) purify and characterize mouse BM180 using HPLC and capillary electrophoresis, and (2) initiate studies examining BM180-intestinal cell interactions.